Zeiss LSM 980 confocal with Airyscan 2

Project Summary
This instrumentation request is for funds to purchase a Zeiss LSM 980 confocal with Airyscan2
microscope to upgrade obsolete confocal microscopes that are approaching the end of their
useful lifetimes and are inadequate for life cell imaging. This instrument will be housed,
managed, and maintained by the Optical Imaging Core Facility (OIF) at UT Health San Antonio,
which is jointly managed by the Office of Vice President for Research and the Mays Cancer
Center. The OIF supports more than 80 NIH-funded investigators’ labs, with confocal
microscopy accounting for over 70% of the facility's usage. Last year alone, the OIF supported
76 externally funded research projects with a total award amount of more than $60 million. The
acquisition of this new microscope is considered essential in order for the OIF to continue
providing the needed services to a large number of NIH-funded research projects. The new
instrument is particularly critical to the major users listed in the proposal, whose highly
competitive and innovative research is dependent on the availability of this instrument.
Investigators, including both well-established and new investigators from diverse research
areas, will greatly benefit. The new instrument can truly lead to a better understanding of basic
biological systems and to develop novel therapeutic strategies in treating many diseases states,
including various types of cancers, brain injury, degenerative neurological disorders, immune
system disorders, atherosclerosis, and liver disease. The availability of this new instrument will
also stimulate other investigators at UT Health SA and nearby institutions to move their
research into exciting and highly competitive new directions. Overall, this acquisition will without
a doubt, significantly impact a large number of NIH-funded investigations covering an expansive
array of disciplines in biomedical research.

Public health relevance
Project Narrative: The requested instrument is a crucial tool needed by a large number of investigators in their research to understand and elucidate basic biological systems and ultimately, to create novel therapeutics against many diseases, including various types of cancers, brain injury, degenerative neurological disorder, immune system disorder, atherosclerosis, and liver disease.